Assembly and epigenetic inheritance of the human centromere

Project Summary Chromosome missegregation and aneuploidy are commons characteristics of cancer. Centromeres are chromosomal loci that define the site of kinetochore formation and ensure faithful chromosome segregation during mitosis. Centromeric identity is epigenetically specified by the incorporation of CENP-A nucleosomes, independent of DNA sequence. Because of the chromatin nature of the centromere, the processes that govern CENP-A nucleosome assembly and nucleosome stability are essential to the maintenance of centromere specification. New CENP-A must be added to the centromere in a consistent and faithful manner during each cell cycle to maintain centromeric chromatin and centromere identity. New CENP-A nucleosomes are added to the centromere during G1 by the CENP-A specific chaperone HJURP, that is recruited to centromere by the Mis18 complex. Although unlike canonical histone H3, new CENP- A is not deposited during DNA replication; however, CENP-A nucleosomes are retained at the centromere during DNA replication to ensure the transmittance of the centromeric locus. The mechanism by which CENP-A nucleosomes are stably retained when chromatin is disassembled during DNA replication will be addressed in this application. Centromeres are located within the alpha-satellite DNA repeats in most individuals; however, several neocentromeres have been identified where centromere proteins relocate and function at non-centromeric sites. This application will address the ability of non-centromeric sites to acquire centromeric identity in order to understand the chromatin and genomic contributions to centromere function.

Public health relevance
Project Narrative How the genome is faithfully segregated during each cell division is a fundamental question in biology, with implications for understanding the genesis of cancer. Chromosome segregation is controlled by the centromere, which is specified by a unique nucleosome containing the histone variant CENP-A. Our work will discover new mechanisms that explain how centromeric chromatin is assembled and maintained.